TVDIL Infrastructure for CVM VET-LRN Veterinary Diagnostic Laboratory Program

Project Summary/Abstract
Foodborne diseases are major public health burden in the United States. This project will
provide necessary infrastructure and surge capacity for microbiology testing in a food/drug
emergency or an outbreak situation. The Tifton Veterinary Diagnostic and Investigational
Laboratory has the necessary infrastructure including a state of the art facility and qualified
personnel, and is willing to meet the objectives of this RFA.

Public health relevance
Project Narrative The objective this proposal is to provide infrastructure for sample analysis and surge capacity to the VetLIRN in the event of animal food or drug related emergency or as needed by the VetLIRN program. The funding will also be used for maintaining trained personnel and quality control procedures and for the proficiency testing procedures as appropriate.